Sleep and affective disturbances in the etiology of Alzheimer's disease

Project Summary / Abstract
Alzheimer's disease (AD) is a devastating age-related neurodegenerative disease that can severely curtail life
quality and expectancy. Depression and sleep disorders manifest decades before disease onset and may serve
as an important early biomarker. Serotonin (5-HT) neurons in the dorsal raphe nucleus (DRN) exhibit
neurofibrillary changes in the early stages of AD, which may contribute to some of these early non-cognitive
symptoms. The goal of this application is to determine whether tau accumulation in 5-HT DRN neurons induces
depressive-like behaviors and disordered sleep, leading to chronic sleep disruption. These sleep deficits, in turn,
may promote hyperexcitability of 5-HT neurons and lead to neurodegeneration. The increased activity in 5-HT
neurons due to sleep deprivation also facilitates the spread of tau pathology to the entorhinal cortex (EC), another
region that is impacted early in the course of AD. Loss of 5-HT inputs from the DRN to the EC will disinhibit
neurons that project to the hippocampus, precipitating tau spread and the onset of cognitive and memory
problems. In Aim 1, we will use in vivo fiber photometry to measure neural activity in 5-HT neurons during tests
of depressive-like behavior in mouse models of tauopathy to see if the normal function of these neurons is
negatively impacted. We will also monitor 5-HT activity during sleep to see if that is altered by tau pathology. In
Aim 2, we will examine the effect of sleep deprivation on 5-HT neuronal excitability and the progression of tau
pathology in the brain using electrophysiology and 3D imaging. The role of increased neural activity in 5-HT
neurons on the spread of tau pathology will also be examined using chemogenetic manipulations of neural
activity. In Aim 3, we will determine whether tau-induced loss of 5-HT inputs to the EC alters 5-HT signaling in
principal neurons that project to the hippocampus. We will also establish a role for 5-HT/5-HT2A receptor signaling
in the spread of tau pathology to the hippocampus and the onset of cognitive deficits. In total, the proposed
research will provide essential information concerning the impact of tau pathology on early behavioral symptoms
of AD and the later development of cognitive and memory deficits.

Public health relevance
Project Narrative The goal of these studies is to determine whether tau accumulation in serotonin neurons causes affective and sleep disturbances, leading to chronic sleep deprivation and hyperexcitability in serotonin neurons and accelerating the spread of tau pathology to the entorhinal cortex. The resulting loss of 5-HT input to the EC also enhances excitability of EC neurons that project to the hippocampus, promoting spread to this region and precipitating cognitive decline. Ultimately, this investigation may identify neural substrates underlying the early non-cognitive symptoms of AD which could lead to better treatments for this devastating disease.